Incubation of oxycodone craving and nucleus accumbens plasticity

Project Summary
We will use the `incubation of craving' model to study a major challenge in treating opioid addiction, namely the
persistence of vulnerability to cue-induced relapse even after long periods of abstinence. In this model, rats show
progressive intensification of cue-induced drug craving in the weeks after discontinuing drug self-administration
(SA); craving then plateaus at a high level before declining. We will study incubation of craving for oxycodone
(Oxy), an opioid with a high abuse rate. Previously, we and others found that Ca2+-permeable AMPARs (CP-
AMPAR) accumulate in synapses on nucleus accumbens (NAc) medium spiny neurons (MSN) during forced
abstinence from cocaine or methamphetamine SA, strengthening these synapses and mediating expression of
incubated craving. Our preliminary data show that CP-AMPARs also increase in NAc during Oxy incubation and
are required for its expression, but the pathways into NAc that undergo CP-AMPAR upregulation and drive
incubated Oxy seeking are unknown. To address this, we propose cell type (D1 vs D2 MSN), subregion (core vs
shell), and pathway specific studies comparing saline and Oxy rats in early and late withdrawal (i.e., before and
after incubation). Transgenic rats with Cre in D1 or adenosine 2a (A2a) receptor-expressing cells (D2 and A2a
receptors colocalize in MSN) will be used to distinguish D1 and A2a/D2 MSN. Pathway specific studies will focus
on glutamate inputs from basolateral amygdala (BLA) and paraventricular nucleus of the thalamus (PVT); both
are implicated in Oxy incubation by our preliminary data. We hypothesize that cues previously paired with Oxy
SA activate specific BLA- and PVT-NAc MSN pathways via CP-AMPARs and thereby drive incubated Oxy
seeking. This will be tested by integrating electrophysiological and chemogenetic data across Aims. In Aim 1,
we will first assess excitatory synaptic transmission, including the contribution of CP-AMPARs, in D1 and A2a
MSN in NAc core and shell during Oxy incubation. Preliminary data show elevated CP-AMPARs in both D1 and
A2a MSN after Oxy incubation, contrasting with D1 MSN only after cocaine or methamphetamine incubation.
Then, we will use chemogenetics to determine if inhibiting D1 or A2a MSN in core or shell prevents expression
of Oxy incubation. Aim 2 will assess excitatory synaptic transmission in the BLA-NAc pathway (D1/A2a MSN,
core/shell) and use chemogenetics to test the role of BLA inputs in incubated Oxy seeking. In Aim 3, we will
perform parallel electrophysiological and chemogenetic studies for the PVT-NAc pathway. Interestingly, prior
work has shown that, in morphine-dependent rodents, CP-AMPAR upregulation in PVT-shell A2a MSN synapses
mediates aversive states of opioid withdrawal. Thus, to help interpret our PVT-NAc studies and potentially set
the stage for future studies on the interaction between positive and negative reinforcement in driving incubation,
Aim 3 will determine if negative affective states, which contribute to relapse in opioid users, are detected
alongside incubation of Oxy craving. Our studies will be the first to investigate the role of NAc synaptic plasticity
in Oxy incubation and the first to study negative affect following protracted withdrawal from Oxy SA.

Public health relevance
Project Narrative Exposure to cues associated with opioid use can trigger relapse in recovering opioid users, even after long periods of abstinence. The proposed experiments focus on oxycodone, a widely prescribed opioid analgesic that is a significant contributor to the opioid crisis. Our rat studies will be the first to assess the role of synaptic plasticity in the nucleus accumbens, a critical brain region for motivation and reward, in the maintenance of oxycodone craving during protracted withdrawal from oxycodone self-administration.